PALATABILITY OF AMONO ACID BEVERAGES IN HEALTHY SUBJECTS

Primary Objectives: Establish the acceptability and efficacy of a new flavoring method for amino acid mixtures use as challenge diets in tests of tryptophan depletion. Normal subjects will be recruited to ingest mixtures of amino acids that are currently used in studies of dietary effects on mood. The current formulation of this tryptophan deficient mixture is usually described as revolting, at best, and can sometimes cause nausea and rarely vomiting. This response could influence studies of mood because the nausea is stressful. In the present tests, new flavoring and preparation procedures will be tested for palatability. Palatability will be compared between two flavoring methods. We hypothesize that a palatability scale will show no significant difference between ratings for the new test diet and ratings for the meals eaten 24 hours prior to screening, while the old flavoring will be significantly worse.